DNA Damage and Immunogenicity in Ewing Sarcoma

The goal of this career development award is for the applicant to expand her knowledge and technical expertise
in tumor immunology and bioinformatic analyses in order to apply these new skills to investigation of the
childhood cancer Ewing sarcoma. Relapsed Ewing sarcoma is nearly uniformly fatal, and thus new treatment
approaches are desperately needed. A growing number of immune-based therapies are now being incorporated
into pediatric cancer treatment protocols. Thus, in order to be a successful clinician scientist directing a cutting-
edge research program in Ewing sarcoma, it is essential that the applicant gain expertise in tumor
immunobiology. Currently, very little is understood about regulation of the Ewing sarcoma tumor immune
microenvironment. This proposal addresses the interplay of two broadly important facets of pediatric cancer
research: DNA damage repair and tumor immune response. This proposed work specifically examines the ability
of DNA damage to activate Ewing tumor cell immunoregulatory pathways. The proposed aims will utilize a
combination of in vitro cell co-culture analyses, in vivo tumor animal modeling and human specimen analyses in
order to address this important topic. The applicant has chosen a primary mentor who is an expert in
immune/inflammatory signaling in cancer, and a co-mentor with expertise in T-cell biology and advanced
immunology techniques. Additionally, the applicant has constructed a physician-scientist career mentoring
committee and network of collaboartors including individuals with expertise in Ewing sarcoma, humanized mouse
models, DNA damage repair, the tumor immune-microenvironment, and bioinformatic analyses. As a team, the
mentor, co-mentor, committee members and collaborators are dedicated to providing the applicant with
technique training in tumor immunology and advanced cancer biology, as well as critical feedback on grants and
manuscripts and career guidance. The primary mentor and co-mentor are invested in guiding the applicant
toward a highly successful career as physician scientist by transitioning her to senior authorship on manuscripts,
preparing her to start an independent laboratory and encouraging her to directly mentor scientists and clinicians
at various levels of training. The University of Pittsburgh is an outstanding environment in which to develop a
career and expand a research program in tumor immunobiology. The applicant’s career development plan takes
full advantage of the many unique offerings at Pittsburgh including face-to-face career development workshops
with seasoned scientists, participation in the Pittsburgh Women in Science forum, graduate level tumor
immunobiology and bioinformatics courses and opportunities for presentation of work-in-progress at the
University of Pittsburgh Cancer Immunology Program meetings. With the enthusiastic support and exceptional
scientific expertise of her mentor and co-mentor, the applicant is eager to gain specific training in tumor
immunobiology and bioinformatic analyses and to launch an independent research career as a pediatric
oncologist physician scientist studying Ewing sarcoma at the University of Pittsburgh.

Public health relevance
This work aims to better understand the pediatric cancer Ewing sarcoma, specifically investigating the immunobiology in the setting of tumor DNA damage. The studies will be performed by examining the cancer cells themselves as well as by examining the immune cells in proximity to the tumor that can influence growth and spread of the cancer. This career development grant will provide the applicant with training in tumor immunology and bioinformatic analyses, an area of growing importance in pediatric oncology.